Optimice 100-Cage IVC System

ABSTRACT
Thomas Jefferson University’s (TJU) Laboratory Animal Services (LAS) department is
responsible for providing all laboratory animal services across 3 buildings on campus. LAS
supports the animal research needs of 125 active principal investigators (PIs), ~8,500 rodent
cages, and ~282 active IACUC protocols on the TJU campus who have research funding/grants
totaling over 170 million dollars. Our oldest animal facility on campus (originally constructed in
1968), has undergone over 140 million dollars in research renovations over the last 7 years. The
facility in this building currently supports the animal research needs of an estimated 50 TJU PIs.
While the older portions of the facility are of sound design and quality, the primary deficiency
within the more popular bio-exclusive and conventional rodent housing rooms on two main
floors is modern caging, specifically individual ventilated caging (IVC). These facilities remain
heavily used by researchers and the modernization of IVC systems is critical for rodent welfare
and operational efficiency. The dedication of the University to help modernize the animal
facilities has been paramount for research progression over the last 7 years. The addition of the
IVC system would be a continuation of the modernization strategy that senior leadership
continues to support to meet the growth and expansion of our animal and care program. Direct
research benefits include a 25% increased room census capacity to allow for increased internal
studies and collaborative projects within our cores such as the NCI-designated Comprehensive
Cancer Center. Also, the transition to the newer IVC system will provide a continued attractive
incentive for prospective researchers looking to perform work at TJU as senior leadership
continues to recruit and expand the TJU research portfolio. Expansion of the IVC system
equipment to two older rooms on these floors would help meet the needs of our faculty
researchers and LAS animal husbandry staff. Specifically, the IVC system would afford 1)
enhanced animal health and well-being due to reduced stress from handling, which in turn
would enhance reproducibility and robustness in animal research data; 2) increased continuity
of IVC rack/caging system across the LAS facility; and 3) increased operational efficiency for
animal facility staff, clearing time for husbandry personnel to devote to other important duties
related to animal care. Equipment modernization now with IVC racks and cages in areas
targeted for renovations in the future will help address the immediate needs of the animal
research facility, its users, and its staff and provide the benefits of modernization during the
interim period between major stages of renovation in our overall LAS modernization plan.

Public health relevance
Narrative The objective of this proposal is to purchase and install modern and ergonomically friendly, individually ventilated cage (IVC) systems in some of our rodent housing rooms, to enhance and modernize an existing older rodent facility. By replacing the current static microisolator caging system, we will i) improve and streamline operating processes, ii) increase census capacity by 25% in the selected rooms, iii) decrease animal stressors related to more frequent cage changing, and iv) get closer to IVC continuity and increase consistency in animal research conditions within this animal research facility. This continuity with animal husbandry and operations will increase research capacity within our collaborative cores and maintain research reproducibility of Jefferson’s animal research projects with the harmonization of caging systems in our facilities.